Evaluating the mechanism by which the DYNLL1-MRE11 complex regulates DNA end resection and genome stability.

PROJECT SUMMARY
The synthetic lethal interaction of BRCA deficiency with PARPi is being exploited therapeutically in diverse
clinical contexts, including ovarian, pancreatic, and prostate cancers). However, PARPi resistance has emerged
as a vexing clinical problem for the treatment of BRCA1/2-deficient ovarian cancer carcinomas. Analyses of
PARPi resistance in BRCA1-mutant tumors across independent studies suggest that loss of genes involved in
either promoting NHEJ or suppressing HR leads to the partial restoration of HR in the absence of BRCA1 activity.
53BP1 emerged as the master regulator that brings multiple complexes to the DSB. Loss of any of these factors
causes PARPi resistance in BRCA1 mutant cells. Therefore, further understanding of factors that regulate the
processing of DNA ends that are crucial for pathway choice have tremendous relevance in cancer biology.
Our lab has previously identified that in ovarian cancer cells, loss of DYNLL1, a factor that is constitutively
bound to 53BP1, also results in enhanced HR and PARPi resistance. We found that DYNLL1pS88 directly binds
to and inhibits MRE11, thereby blocking the initiation of DNA end resection. However, how the interaction of
DYNLL1 with MRE11 impairs its nuclease activity or its recruitment to foci remains unexplored. Furthermore,
how this interaction is regulated in the context of the DNA damage response, for example, which
kinase/phosphatase(s) regulates the phosphorylation of S88 residue of DYNLL1 to modulate its interaction with
MRE11 needs to be investigated.
Our overall objectives in this application are to identify the molecular mechanism(s) regulating repair
pathway choice by further understanding how end resection proteins are regulated. Our central hypothesis is
that cell cycle-specific regulation of DYNLL1 promotes BRCA1/BARD1 mediated ubiquitination of MRE11,
thereby facilitating end resection at DSBs in S phase.
We aim to understand the mechanism by which DYNLL1 mediates end resection and HR. We will first
investigate the dynamics between BRCA1 and DNA-PKcs and how it regulates the DYNLL1 and MRE11 activity
in the context of the cell cycle. Investigating the dynamics of these end resecting factors and their regulation in
DSB repair bear significant clinical relevance in combating PARPi resistance in BRCA1-mutant tumors.
Therefore, we propose to determine whether alterations in mechanisms involved in attenuated DNA end
resection may drive development of PARPi resistance in the high grade serous ovarian cancer (HGSOC) using
patient derived xenografts (PDXs) and primary tumors. We expect that these studies will further our
understanding of how end resection machinery is regulated to ensure that the appropriate repair pathway is
activated. Further understanding of these end resection factors and how they are dysregulated in cancer may
lead us to a relevant therapeutic target to combat PARPi resistant cancers.

Public health relevance
PROJECT NARRATIVE The synthetic lethal interaction of BRCA deficiency with PARPi is being exploited therapeutically in diverse clinical contexts (breast, ovarian, pancreatic, and prostate cancers); however, PARPi resistance has emerged as a vexing clinical problem for the treatment of BRCA1/2-deficient carcinomas. Analyses of PARPi resistance in BRCA1-mutant tumors suggest that loss of genes involved in blocking end resection during HR leads to the partial restoration of HR in the absence of BRCA1 activity. This proposal seeks to evaluate the regulation of these end resecting factors and how they can be exploited to identify and develop novel cancer therapeutics to lessen the burden of disease.